REGULATION OF INTERLEUKIN 6 AND INTERFERON PRODUCTION

The major thrust of our research during the last several years has been the detailed characterization of novel "interferon" mRNA species induced by poly(I) poly (C) in diploid human fibroblasts: a 1.3 kb "interferon-beta2" species and a 1.8 kb "interferon-beta3" species. The cytokine, to which we originally applied the name "interferon-beta2" and which is now called "interleukin-6," has emerged as a major systemic alarm signal produced in response to tissue injury. IL-6 phosphoglycoproteins (size range 23-30 kDa) in turn affect the function of a wide variety of different cell types. IL-6 elicits major changes in the biochemical, physiological and immunological status of the host (e.g. the "acute phase" response.) We have developed a broad research program which has already provided key insights into the structure and function of human IL-6. We propose to continue this effort in the following areas: I. MOLECULAR BIOLOGY: The hallmark of IL-6 gene regulation is the induction of the gene in many different tissues by inflammation-association cytokines (IL-1), TNF, PDGF, other IFNs). We plan to conduct detailed investigations of the following: cis-acting regulatory DNA elements in the IL-6 promoter and trans-acting wild-type and mutant transcription factors involved in the regulation of this gene, particularly focusing on the 23-bp MRE identified by us; tissue-specificity of IL-6 induction and the molecular events that lead to constitutive vs. inducible expression of IL- 6. II. BIOCHEMISTRY: Different tissues secrete multiple forms of IL-6 which are post-translationally modified. We plan to characterize these modifications; characterize the biochemical nature of IL-6 in human body fluids (particularly the 45 kDa IL-6 complex) and carry out structure- activity studies of natural and recombinant IL-6 proteins. III. CELL BIOLOGY: IL-6 regulates expression of specific genes in several different target, cells. We propose to explore the effects of IL-6, alone and in combination with IL-1, TNF and IFN-gamma, on plasma protein secretion by hepatocytes, monocytes and fibroblasts; characterize the novel IL-6 "receptor" mRNA species found in fibroblasts and investigate the inhibition of epithelial cell proliferation by IL-6. IV. PATHOPHYSIOLOGY: High IL-6 levels are found in plasma and body fluids in acute inflammatory disease states. We shall investigates the significance of altered IL-6 levels (systemic and local) in patients with acute and chronic infections, neoplasia and autoimmune diseases; and explore the association between IL-6 haplotypes and specific disease states.